Dynamic control of actin network architecture in early C. elegans embryos

Project Abstract/Summary
Cells utilize an array of actin binding proteins with diverse and complementary properties to
assemble, maintain and disassemble a range of distinct F-actin networks to facilitate different
fundamental functions including motility, polarization and division. To serve its function, each of
these networks has a unique architecture defined by the number, lengths and connectivity of its
filaments, which is maintained by a continuous dynamical balance of actin filament assembly,
remodeling and disassembly. A fundamental challenge is to understand how functional network
architectures are formed and maintained by the continuous coupling of architecture and
assembly dynamics. Here we are focusing on the cell cortex, a dynamic network of actin
filaments, crosslinkers and myosin motors, lying just beneath the plasma membrane, that
undergoes rapid deformation and flow to drive cell movement, polarization, division and tissue
morphogenesis. How ensembles of actin regulatory factors work in concert to simultaneously
regulate actin filament network architecture assembly and dynamics at the cortex of living cells
is poorly understood. The one cell C. elegans embryo provides a uniquely powerful opportunity
to address these questions in a single large cell, that is directly accessible to high resolution
microscopy, with powerful genetics, transgenics, CRISPR and RNAi. The C. elegans cortex is
primarily composed of an F-actin network of linear filaments and small filament bundles that are
assembled by formin CYK-1-mediated polymerization of profilin-actin, and decorated by actin
filament crosslinkers plastin PLST-1, anillin ANI-1, and by mini-filaments of non-muscle myosin
II NMY-2. Conversely, cofilin UNC-60A and capping protein CAP-1/CAP-2 appear to be key
regulators of filament disassembly and filament length, respectively. We are addressing how the
C. elegans cortical F-actin network architecture is formed and maintained through the dynamic
integration of formin-dependent filament assembly, filament crosslinking, filament capping, and
cofilin-dependent filament disassembly, all while the network experiences continuous myosin-
driven deformation and flow. We are combining the complementary state-of-the-art in vivo
expertise (quantitative single molecule imaging and particle analysis) and in vitro expertise
(reconstitution and biophysical analysis) of the Ed Munro and David Kovar lab’s to address two
major questions concerning the architecture and dynamics of the C. elegans F-actin cortex.
First, we will characterize the fundamental dynamics, regulation and feedback control of formin-
mediated actin filament and bundle assembly (Aim 1). Second, we will investigate the
fundamental dynamics, regulation and feedback control of cofilin-mediated actin filament
disassembly of the formin actin filament networks (Aim 2).

Public health relevance
Project Narrative The goal of this work is to understand how cells govern the architecture and assembly dynamics of cortical actin networks that control cell shape, cell polarization, cell division and tissue morphogenesis. To achieve this, we will use a powerful combination of in vitro reconstitution assays and quantitative microscopy.